Core A

The main purpose of this Core, which consists of a half-time Project Coordinator, and a small operating budget, is to provide Dr. Sun, the Principal coordinate, in a cost-effective manner, the extremely well during the last grant period